Suspect Treat Organ failure Prevent Sepsis Mortality (STOP Sepsis Mortality)

Project Summary/Abstract
Despite enormous investments in research over the last 30 years, pediatric sepsis remains a leading cause of
in-hospital death, particularly in underserved and minoritized populations. Sepsis is defined as rapidly
progressive, life-threatening organ dysfunction (OD) due to an immune dysregulation as a response to infection.
In the U.S. over 75,000 children are admitted for sepsis annually with an associated mortality rate of 5 to 20%.
Effective timely sepsis management (early/accurate diagnosis and appropriate treatment) is exacerbated by
varying sepsis phenotypes resulting in high heterogeneity in sepsis presentations and responses. Sepsis
phenotypes can result in significant variability in the immune response by disrupting metabolism and adenosine
triphosphate (ATP) levels, affecting critical cellular functions including those needed to fight infections. The
pathophysiology of sepsis is linked to an energetic crisis combined with immune-mediated inflammation.
Specifically, cells shift their energy generation from aerobic oxidative phosphorylation (OXPHOS) to less-efficient
glycolysis. Cellular energetic deficiency leads to excess accumulation of reactive oxygen species (ROS) and
subsequently to oxidative stress, inflammation, and cell death. Studies have highlighted a mesenchymal stem
cell (MSC)-related improvement in energetics that is partially achieved by the transfer of bioactive molecules
such as miRNAs and proteins carried by secreted extracellular vesicles (MSC-EVs). Neonates and young
children are particularly vulnerable to energy deficits during sepsis due to their limited energy reserves, higher
metabolic rates, and immature organ systems. Early sepsis recognition and timely treatment with appropriate
antibiotics, IV fluids and/or vasopressors can reduce mortality. Additionally, there is no therapy that directly
targets the pathophysiologic changes of sepsis such as the concurrent disrupted energy-generating metabolic
processes and immune dysregulation, especially in organs most affected by sepsis such as the brain and the
lungs. To develop new therapeutic protocols for sepsis, our team has been investigating the use of MSC-EVs in
alleviating sepsis-induced immune and metabolic dysfunction with encouraging results. In summary, I have
established a program that aims to decrease sepsis mortality in the pediatric population by 1) using an AI-guided
early identification tool, 2) performing sepsis phenotyping and a digital twin patient model to predict personalized
treatment response and 3) developing a cutting-edge extracellular vesicle-based therapeutic protocol. I have
made significant contributions to the scientific community by providing mentorship to students from diverse
backgrounds and service to professional societies, peer review panels and journal editorial boards. I’m
committed to creating a diverse team and an inclusive environment with the goal of decreasing sepsis mortality
and potential long-term effects and improving the lives of many vulnerable children and especially those from
marginalized populations.

Public health relevance
Project Narrative/Public Health Relevance Statement: Sepsis has been linked to 20% of deaths worldwide and despite some recent advances in diagnostic tools, the lack of accurate definitions and heterogeneity of this clinical syndrome have led to delays in recognition and treatment with deleterious effects on the health of millions of children, especially those from minority groups. Additionally, current sepsis therapeutic regimens are mostly supportive, lack the necessary personalization and fail to address the underlying physiological processes leading to sepsis-induced life threating organ failure. This application proposes to establish a comprehensive sepsis program that will include a diagnostic AI-based, biomarker-enhanced platform for early recognition of pediatric sepsis, a digital twin patient model to predict personalized treatment response and cutting-edge, extracellular vesicle-based therapeutics that can significantly decrease mortality and long-term disease sequelae.